Stanford MoTrPAC Bioinformatics Center

Abstract
Few interventions have been shown to be as beneficial to human health as physical activity, yet we remain
largely ignorant of the mechanisms by which these potent health effects are transduced. The Molecular
Transducers of Physical Activity Consortium examines the response to acute and chronic exercise at
multiple scales and in multiple tissues across thousands of humans and in animal models. MoTrPAC combines
multi-scale phenotyping with molecular multi-omics approaches. Building on our long history of analytical
innovation in high throughput biology and computational innovation, the Stanford MoTrPAC Bioinformatics
Center will provide computational, bioinformatic and analytic expertise to the Consortium. Leveraging
scalability and reproducibility approaches enabled by cloud architecture, we provide a robust platform for the
sharing and analysis of multi-tissue, multi-omic, physiological and sensor based measurement data. Aim 1 is
focused on advancing our cloud-based data warehouse for raw and processed data. We will achieve this by
extending work enabling data access and data processing, advancing data management and scalable search.
Aim 2 implements existing omics pipelines and the development of new pipelines for human multi-omic data.
In addition, we extend analytic approaches for multi-scale, high-throughput data from human and animal
studies. We will expand robust data analysis pipelines and code repositories built with FAIR principles in mind.
In addition, we will continue incorporating data integration and novel visualization approaches. Aim 3 expands
and extends our interactive interface for investigators and the public to interrogate, interact with, explore, and
download MoTrPAC data. In addition, deposition of MoTrPAC data to durable, public repositories and of code
and analysis packages to public collaboratories, together with dissemination activities developed by the BIC on
behalf of the Consortium will extend the utility and utilization of the work of the Consortium to advance the
science of physical activity. With the expertise, experience, infrastructure and tools already in place, the
Stanford MoTrPAC Bioinformatics Center is well-positioned to deliver on the vision of MoTrPAC, from data
collection, processing and analysis to exploration and dissemination.

Public health relevance
Project Narrative The health benefits of physical activity are manyfold yet we do not know the molecular pathways through which these benefits are mediated. The Molecular Transducers of Physical Activity Consortium (MoTrPAC) will examines the biological response to exercise using state of the art tools across thousands of humans and in animal models. The Stanford MoTrPAC Bioinformatics Center provides infrastructure, informatics, and analytic expertise, to manage, interpret and disseminate the data resources generated by the Consortium.